CLINICAL RADIATION PHYSICS SERVICE

The Section continues to provide expert physical and technological support for radiation treatment, consisting of routine calibration and quality assurance of all radiation equipment. It includes special dosimetry studies, computer-assisted treatment planning, and the design and development of special equipment tailored to developing clinical needs.